Impact of Antibiotics and Vaccines on the in vivo Evolution of S. pneumoniae

C'! of S. pneumoniae" 1R01AI01808903953-051-OA1IAI "Impact of Antibiotics and Vaccines on the in vivo Evolution CO) "Impact of Antibiotics and Vaccines on the in vivo Evolution 3.0 m Streptococcus pneumoniae has remained one of the major causative agents of potentialylifethreattenininghumandiiseaseininourerra.. Nevertheless, introduction of antibiotics (peniciillliin)and- more recently - ttheconjjugate vaccine provoked majjor evolutionary changes in the structure of natural populations of this pathogen. The purpose of this research proposal is to combine the power of whole genome sequencing (WGS) and epidemiology to obtain insights into the mechanisms by which antibiotic resistant and non-vaccine type pneumococcal lineages emerged in the in vivo environment. The studies will have three foci of concentration. Proiect I. Three highly penicillin resistant pneumococcal (PRPn) clones: ST-I, ST-2 and ST-3, each with a unique sequence type (MLST) and capsular type have achieved pandemic spread and appear to remain stable over long times and distant geographic sites of isolation. Such genetic stability in a highly recombinogenic pathogen is unusual and it contrasts with the well documented diversity of penicillin susceptible pneumococci. The purpose of this project is to use whole genome sequencing (WGS) to better document and understand the nature and mechanisms of genetic stability in these three PenR clones. Proiect II. Pneumococcal strains expressing the non-vaccine type (NVT) capsular polysaccharides, such as 1 IA, 6A or 1 9A have been identified as minority components of the nasopharyngeal flora of children attending Day Care Centers - even before the introduction of the conjugate vaccine. WGS will be used to test if the emergence of these strains from minority to majority status in the nasopharynx and from is accompanied by changes in genetic makeup Because the pandemic penicillin-resistant strains show much less genomic variation over time and distance than the nonclonal strains, structure from the nonclonal types we will investigate these strains to see if they are less recombinogenic and/or limited with respect to donor DNA source as opposed to being less capable or less likely to form mixed strain biofilm structures with penicillin-sensitive strains thus resulting in lower rates of inter-strain transformation and evolution. =(D f/1 colonizers to disease causing strains - is accompanied by changes in genetic makeup rates of inter-strain transformation and evolution. mixed strain biofilm structures with penicillin-sensitive strains thus resulting in lower respect to donor DNA source as opposed to being less capable or less likely to form cell wall structures are profoundly different in structure from the nonclonal types we will genomic variation over time and distance than the nonclonal strains, and because their investigate these strains to see if they are less recombinogenic and/or limited with Proiect Ill. Because the pandemic penicillin-resistant strains show much less r-. cell wall structures are profoundly different in colonizers to disease causing strains - three Pen capsular polysaccharides, components of the nasopharyngeal flora of children attending Day Care Centers - emergence of these strains from minority to majority status in the nasopharynx and from before the introduction of the conjugate vaccine. is unusual and it contrasts with the well documented diversity of penicillin susceptible better document and understand the nature and mechanisms of genetic stability in these ST-2 and ST-3, each with a unique sequence type (MLST) and capsular type have geographic sites of isolation. purpose of this research proposal is to combine the power of whole genome sequencing pneumococci. resistant and non-vaccine type pneumococcal lineages emerged in the in vivo evolutionary changes in the structure of natural populations of this pathogen. environment. achieved pandemic spread and appear to remain stable over long times and distant (WGS) and epidemiology to obtain insights into the mechanisms by which antibiotic Project III. Project II. Project I. R clones. The studies will have three foci of concentration. The purpose of this project is to use whole genome sequencing (WGS) to Three highly penicillin resistant pneumococcal (PRPn) clones: Pneumococcal strains expressing the non-vaccine type (NVT) such as Such genetic stability in a highly recombinogenic pathogen 11A, 6A or 19A have been identified as minority +-' WGS will be used to test if the and because their ST-1, even '"; -0-0 O." 0-0 (/1 .,, ... O-2 Z E 0-0 (gyp f0/1 8)o +L-' I-a) 53' =_i. RevisedSpecific Aim Section 1R01AI108008903953-50-1OAI1AI""IImpactofAntiibiotics and Vaccines onthe invivo Evolution of S. pneumoniae" 00p Below are themodified specific aims we propose to complete within the two year funding period groups of strains; build gene-sharing trees showing the evolutionary relationships among strains and metabolic reconstructions among the isolates'sequences identified in SA-1a and b to the same time;2) isolates of the same clone recovered from multiple children attending on different continents;and 5) isolates recovered over long time periods of the same pandemic clone recovered from various disease sites in different countries clone recovered from children in different DCCs within weeks of one another;4) isolates the same day care center (DCC) at the same time;3) isolates of the same pandemic -U) Perform whole genome alignments, and bioinformatic comparative genomic and the same day care center (DCC) at the same time; clone recovered from children in different DCCs within weeks of one another;4) isolates on different continents;and 5) of the same pandemic clone recovered from various disease sites in the same time;2) isolates of the same clone recovered from multiple children attending constellation of sources including multiple: 1) isolates recovered from the same child at c: isolates recovered over long time periods 1) isolates recovered from the same child at 3) isolates of the same pandemic different countries y.0 SA-1 Perrfforrmwhollegenomesequencing (WGS) and comparative genomic analyses among:: 1)Spcarrriaiageisisolalatetessoffththeeppaannddeemiciclcolnoen,eS, PS1PI(N(N=10);2) Sp carriage isolates the pandemic clones SP2, &SP3 (n's = 4 and 4, respectively), and 3) invasive isolates of SP1I, 2, &3(n = 16) aswell as 8 nonclonal invasive isolates to: a: detetermrminineififththesuprragenomeofftthepandemiciccllonesiis restricted in size compared with the nonclonal clinical Sp isolates (as suggested by ourpreliminary results examining a limited numberofSP-1 isolates) b: by characterizing nasopharyngeal (NP) isolates from pre-school age children (as it is generally agreed that the NP is the primary site of Sp evolutionary change) from a constellation of sources including multiple: --(Q ,-. N-.0 (s] CAN cap 3:r O7y qty frail metabolic reconstructions among the isolates sequences identified in SA-la and b to groups of strains; build gene-sharing trees showing the evolutionary relationships among strains and c: Perform whole genome alignments, and bioinformatic comparative genomic and -[unreadable]O [unreadable]-U C.-.0 (L) 0)0' infection model. the strains are derived from the known pandemic strains;2) if there are novel clones vitro tissue culture assays for adherence and invasion;and 2) the mouse intraperitoneal against themselves and all other sequenced pneumococcal strains to see: emerging;and 3) a: analyze the WGS from SA-1 b: characterize the colonizing and disease potential of these strains by using 1) in L-. which, if any of the other Sp they cluster with evolutionarily. SA-2: Thepaththogenicicppotetentitaialloffpneumococallsttrraininsselelecttedbyttheconjjugate vaccine is unknown. Thesenon--vaciinetype(NVT)straiinscould beeither: a) an expansion of NVTstrains pre-existing as minority isolates at colonization sites;orb) the products of recombination in which "successful" clonal lineages acquired novel NVT capsules. Thepurposeoftheproposed experiments are to a: analyze the WGS from SA-1 from the invasive NVTstraiinsand comparethem against themselves and all other sequenced pneumococcal strains to see: 1) ifany of the strains are derived from the known pandemic strains;2) if there are novel clones emerging;and 3) which, if any of the other Sp they cluster with evolutionarily. b: characterize the colonizing and disease potential of these strains by using 1) in vitro tissue culture assays for adherence and invasion;and 2) the mouse intraperitoneal infection model. acs 4)> 3-p o-[unreadable] O-0 ',[unreadable] mo[unreadable][unreadable]>[unreadable] (Oil SA-3: DetetermrminineeififththeeppeenRstrains: 1) are lless recombinogenicand/orlliimiittedwiith respect to donor DNA source in in vitro transformation experiments;2) are less capable or incapable of forming mixed strain bioflilm structures, and demonstrate lower transformation rates within in vitro biofilms 'off Revised Public Health Relevance Se,d^ction 1R01AI0l080099353-50-1OAI1AI "Impact of Antibiotics and Vaccines on the in vivo Evolution of S. pneumoniae" Narrative to take their place. We will also study the genetics of these replacement types to see if coats (what the vaccine is directed against) or whether these escape strains are truly they possess most of the genes of the clonal lineages that have just hidden in new outer fundamentally alters their cell surface which could limit their interactions with other new with respect to their entire genetics. reducing the incidence of those types, unfortunately other nonvaccine types have arisen introduction a few years ago of a vaccine against some types of Sp was successful in reproductively isolated, or partially isolated, from the rest of the Sp strains. The strains. Therefore, we propose studies to determine if these penR strains have become 'FD Streptococcuspneumoniae (Sp) is a cause of m

Public health relevance
1R01AI080935-01A1 "Impact of Antibiotics and Vaccines on the in vivo Evolution Vaccines on the in 1R01Al080935-OIAI "Impact of S. pneumoniae" S. pneumoniae" Narrative Streptococcus pneumoniae (Sp) is a cause of many human diseases including ear Streptococcus pneumoniae (Sp) cause many human including infections, infections, pneumonia, meningitis (infection of the tissue lining the brain), sepsis, and infectious arthritis, moreover it is the cause of over one million deaths per year arthritis, worldwide. In this application we propose to study the genetics of several penicillinworldwide. In this application we propose study (penR) clonal lineages that have spread around the resistant (penR) clonal lineages that have spread around the world and appear, surprisingly in the context of what we have observed with most other Sp strains, to have surprisingly in with remained to have remained nearly immutable over several decades and across multiple reason for their genetic isolation is that their pen R continents. One possible reason for their genetic isolation is that their penR continents. fundamentally alters their cell surface which could limit their interactions with other fundamentally alters which strains. Therefore, we propose studies to determine if these penR strains have become studies to determine if these pen R strains. Therefore, reproductively isolated, or partially isolated, from the rest of the Sp strains. The reproductively isolated, or partially isolated, from the rest of the Sp strains. introduction a few years ago of a vaccine against some types of Sp was successful in introduction a few years reducing the incidence of those types, unfortunately other nonvaccine types have arisen reducing the incidence types, study to see if to take their place. We will also study the genetics of these replacement types to see if of in new outer they possess most of the genes of the clonal lineages that have just hidden in new outer coats (what the vaccine is directed against) or whether these escape strains are truly new with respect to their entire genetics. with genetics. p.. .-n ,d^ E �'c �-4D '-' toil .,. 0-"-0 .'O. 'FD ..-. o.3 flO.' OMS Number: 4040-0001 0MB Number: 4040~0001 Date: 06/30/2011 Expiration Date: 06/30/2011 � ORGANIZATIONAL DUNS: 0330984010000 *ORGANIThTIONALDUNS: � Budget * Budget Type: ~ Project rI0-3-30-9-S-4-0-'o-o-o-o---------,1 D Subaward/Consortium fl Subaward/Consortium RESEARCH & RELATED BUDGET - SECTION A & B, BUDGET PERIOD 1 RESEARCH & RELATED BUDGET SECTION A & PERIOD I Enter name of Organization: 11eghenysinger Research Enter name of Organization: (Allegheny-Singer Research rnst:\ Start Date: lo7/o1/aaaj * End Date: lO6/3OLZQIOi * Start Date: 107/01120091"End Date: 106/30/20101 A. Senior/Key Person Cal. Budget Period I Budget Period 1 Acad. Sum. Prefix .. First Name * First Middle Name lor. 2. Dr. 2. [pr 1. 3. 4. 5. 5.] 6. 6.1 7. 7.] 11 II 8. 8.1 I IIGarth IlGarth IIFen IlFen I II I I II I II j]ze II II II Ilze I[ I I II I I II II ([o. 110. IF IF U Ilg,874.00 P[j. 214.00 IIEhrlich lJchlPh.Ilph. D. IIlpD/PI o. ,.--------,lIr,-g6-,-7-00-.-0-0-,1~c=Jc=Jb9,340.00 IEiII4. 00 1149,214.00 I[isc, 700.00 112.40 1139,340.00 Ipoipi IlphD I!coinvestiqator I:======",==~11109,990.00 1~c=Jc=JI21,99s.00 IkT21. 00 1\27,519.00 ((Eu J(PhD (los, sso .00112 .40 IIHU [coinvestiqator 1121,996.00 115,521.00 ]]27, 519.00 1I II:====::::;11 ir I II 1c=Jc=Jc=J:=1==::::;I~I====ill:======i (PP Ii IL II -1I II I I ;=====:1:=1===:Ic=Jc=Jc=J1 II 1I:======i II I I I :====::::;11 1c=Jc=Jc=J1 II 11;======i II iF ir I II I :====::::;11 1c=Jc=Jc=J1 II ":======i III ][ ii I I :====::::;1:=1==~Ic=Jc=Jc=J1 II 15,395 ":======i 61,338 ii III - -_ _ _ _ _ull_ _---'Ic=Jc=Jc=JI iF I _J]]I I ' II ":======: I] II II II II .o. I .. Last * Last Name Suffix .. Project Role Base Salary (5) Salary ($) Months Months Months Months Months * Requested .. Requested Salary (5) ($) * Fringe .. Fringe BenefitsCs) Benefits ($) * Funds Requested (5) � Funds Requested ($) P[ 11 1 Pr III II I] II II II II II ____ IF IF II II I II P] II II II II II II PP I[ II 1 I] 1 II I] I] (I II I II II U P Total Funds requested for all Senior Key Persons in the attached file 9. Total Funds requested for all Senior Key Persons in the attached file Additional Senior Key Persons: Additionat Senior Key Persons: B. Other Personnel .. Number of * of Personnel L I_ _ _ _ _ _ _ _ _ _ _ _ _ _ -'1 I II~dd Al\.eilt\AIIi'\~e A�,j.~tr~lli~l~""Rhl)1e.~iII I tt�k!itJ IMSeAtW11 _ ___________________ I TotalSenior/Key Person b6, 733.00 Total Senior/Key Person P76,733.00 I .. Project Role * Project Role Post Doctoral Associates Post P Graduate Students Undergraduate Students Students Secretarial/Clerical c`9 I' Ii 1 I IResearch Associate IResearch Associate IResearch Fellow IRe search Assistant IResearch Fellow P I Ii I I1-1 Is I I I II I I I I 113.60 113.60 113.60 116.00 116.00 II II Other Personnel Total Number Other Personnel I]_______________ II_____________II 11 II II II II II II II II II II 11,5,987.00 1\"013.00 1120,000.00 [7013.oo I tz2,000.oo II 1122,801. 00 115,723.00 1 28,524.oQ 1\28,524.00 5,723.00 I 11,5,001. 00 113,765.00 II,s,766.00 13,765.00 P I'e,mc.oo II 11,6,235.00 1\"075.00 1120,310.00 14,075.00 II F (lo,ao.oo 1128,496.00 117,152.00 1\30,648.00 7,152.00 1135,648.00 II II II 159,858II II 40,123 II II Total Other Personnel 1,23,248.00 123,248 .QQJ Total Salary, Wages and Fringe Benefits (A+B) Salary, Wages and Fringe Benefits (A+B) 1,99,981.00 199,961.00 __ .. Requested Acad. Sum. * Requested Cal.. Cal ($) Months Months Months Salary (5) Months Months Months II I I II FI _I II F] _ I__H__ _ II * Fringe .. Funds Requested ($) Benefits ($) *.. Funds Requested ($) EL' I[ P ___IF____ _ _ _ _ P P P P Requested) RESEARCH & RELATED Budget (A-B) (Funds Requested) {A-B} RELATED BUDGET SECTION C, D, & E, BUDGET PERIOD RESEARCH & RELATED BUDGET -- SECTION C, D, & E, BUDGET PERIOD 1 � ORGANIZATIONAL DUNS: fr33CT34OiO0UO * DUNS: 8'UlOn(,(i I:ee:,; * Budget '" Budget Type: ~ Project o I Subaward/Consortium fl Subaward/Consortium Enter name of Organization: 1.<:L.L,,'qll,~ny-s_~r:,--,~~�- j:(<i,s,.o,arch ;-i~l:,:1 Enter name of Organization: Al.Le.qinny-S�r:ccr: Rnsca rch inst.] * Start Date: k7/o1.'?004h End Date: lnsj.rJ/2o!oI0Budget Period 'I '" Startoate: I)~ I:::: 0 End Date: ::0/2 0 Budget Period 1 h!! / )0,1" Ie,;::; I C. Equipment Description List items and dollar amount for each item exceeding $5,000 List items and dollar amount for each item exceeding $5,000 Equipment item * Funds Requested (5) ($) 1.1 1. 1 2.1 2�1 3�1 4�1 6.1 1 10.1 1�'~1================~:=====: II 11. Total funds requested for all equipment listed in the attached file attached tile 11. Total Fa- 6'1i================~i====~ II 7'1i===============~i====== 8.1 II 8'1i=========================~i====== 9. I II II Total Equipment Additional Equipment: Additional Equipment: p_, I 5�1 1 Ii====~ II Ii====~ II I:====~ II Ii====~ I I I I I I I II 1 II i=C=='=-=== I I I I I ~I~~.�: e=n: t~!M~I~=p=e=le.t~.~; ;'~; ;" ; ;'"."'~vI:; '"' !J=iij I~Vi.WAj~liiilU y~,~,,",,~, .�: � I .. '=" D. Travel D. Travel Funds Requested (5) ($) 1. 2. Domestic Travel Costs ( md. Canada, Mexico and U.S. Possessions) Domestic Travel Costs (Incl. Canada, Mexico and U.S. 11,800.00 Ii 800.00 I___________________ Foreign Travel Costs Foreign Total Travel Cost Ii 800.00 Total Travel Cost 11,800.00 E. Participant/Trainee E. ParticipantlTrainee Support Costs Funds Requested ($) 1. Tuition/Fees/Health Insurance 1. TuitionlFeeslHealth 2. 3. cI 1 I I I Stipends Travel Subsistence Other [L��_ _ _ _ _ _ _ _ _ _ _ _ _ _ _ _ _ _ _---' I 4. 5. 5. I I I c=J Number of Participants/Trainees Number of Participants/Trainees 1 I Total Participant/Trainee Support Costs J ParticipanUTrainee Support Costs , I L I_ _ _ _ _ _- - - ' I RESEARCH & RELATED Budget {C-E}(Funds Requested) RESEARCH & RELATED Budget {C-E} (Funds Requested) 1.'1~19�:1<!Fi!f(IJl"i? �':!l!l!F'" !iI1r~..''''.,. . I RESEARCH & RELATED BUDGET - SECTION F-K, BUDGET PERIOD 1 RESEARCH & SECTION F-K, BUDGET PERIOD I _'I 'ORGANIZATIONAL DUNS: 103309840., .00 ORGANIZATIONAL DUNS: 033098401 3c00 * � Budget Type: I I [g] Project *Startoate: " Start Date: D SubawardiConsortium Subawardlconsorfium Enter name of Organization: j'\ll'Sqh,'"C'l-<;:i.ngf.':r: Fe.sea or ':"h inst:I name eqhe1y-- 3:i.o ger lIes earch :rr.sd End Date:IrjeJ2 J2 (j] :j Budget Period I 10 j!U '.1. /? 0 0 :~J" End Date: I06/::~;/20101IBudgetPeriod 1 Requested ($) Funds Requested (5) F. F. Other Direct Costs 1. Materials and Supplies 2. Publication Costs Costs f`9 1 163,455.00 k,ooo.oo 12,000.00 I 3. Consultant Services ADP/Computer Services 4. I I I I I I 5. 5. 6. Subawards/Consortium/ContractuaJ Costs Subawards/ConsortiumlContractual Equipment or Facility RentalfUser Fees Facility Rental/user Fees {Op 1231,888.00 I I I 7. 7. 8. 8. 10. ________________________________________________ _______ 9. G. Direct Costs G. H. Indirect Costs H. Indirect l�IMTDC JMPDO 2.1 2�1 3�1 4.1 3.1 4j Cognizant Federal Agency IDH-HS-;--Julie Kardell; 412 330 6034 Cognizant Federal Agency 0FIHS; Julie Kardell; 412-330-6034 (Agency Name, poe Name, and poe Phone Number) (Agency Name. P00 Name, and P00 Phone Number) _ 1 Alterations and Renovations Alterationsand Renovations I I L I_ _ _ _ _ _ _ _ _ _ _ _ _ _ _ _- ' I I ~I==============================~ I ~I==============================~ I I I I Total Other Direct Costs 297,343.00 Other Direct Costs 1297,343.00 I Funds Requested ($) Total Direct Costs (A thru F) 1499,124.00 Total Direct Costs (A thru F) 1499,124.00 I Indirect Cost Typo Type Indirect 1148.00 II II II II II II ___ Indirect Cost Rate (%) I Indirect Cost Base ($) Base(s) , Requested ($) * Funds Requested (5) I 11292,236.00 1292,236.00 II II I 1>40,273.00 140,273.00 I II II Total Indirect Costsh ~=40='=27=3=.o=o====: Total Indirect Costs 1140,273.00 II I I II II II II I~I===~ II I~I===~ I I I. Total Direct and Indirect Costs and Total Direct and Indirect Institutional Costs (G + H) Institutional Costs (G + H) Total Funds Requested ($) 1639,397.00 I J. Fee J. Fee (5) Funds Requested ($) Funds I K. Budget Justification IBUdqet Justification ASRI. pdf K."* Budget Justification Ipudqet Justification ASRI.pdf (Only attach one file.) one file.) (Only I I I;-Y;i?~~n~_~~t] I h-~ ;i~~d;~rt~-ri6ii{e-r1r- :;~ I -'NtiiA~_~~h~iefff 2~1 RESEARCH & RELATED Budget (F-K) (Funds Requested) {F-K} 0 Budget Justification Justification Notes: This is a revised ROl application for a previously scored proposal (priority score 191) entitled, "Impact This is a revised R01 application a previously entitled, "Impact of Antibiotics and Vaccines on the in vivo Evolution ofof S. pneumoniae. The researchprogram described Antibiotics and Vaccines on the in vivo Evolution S. pneumoniae. The research program described herein represents a major initiative by two collaborating laboratories: The Center for Genomic Sciences (CGS) herein represents a initiative by two collaborating laboratories: The Center for Genomic Sciences (CGS) at Allegheny Singer Research Institute (ASRI) headed by Garth Ehrlich, and the Laboratory of Microbiology at Allegheny Research Institute (ASRI) headed by Garth Ehrlich, and the Rockefeller University headed by Alexander Tomasz. ASRI will be the contracting institution and Rockefeller Rockefeller University headed by Alexander Tomasz. ASRI will be the contracting institution and Rockefeller reduced will be the subcontracting institution. The budget has been greatly reduced since the original submission which subcontracting institution. The budget has the submission which made possible by a dramatic decrease in perlgenome roll was made possible by a dramatic decrease in per/genome sequencing costs associated with the roll out of the with the Roche 454 LifeSciences Titanium platform. The first year's direct budget is $499,124 with $267,236 going to Roche 454 LifeSciences Titanium platform. The first year's direct budget is $499,124 with $267,236 going to ASRI and $137,200 direct costs going to Rockefeller. The operating costs at ASRI and Rockefeller are subject to institutional F&A charges of 48% and 69%, respectively. This budget is adequate, but is not padded in any 69%, respectively. way, to perform the extensive experimentation (e.g. sequencing of dozens of pneumococcal genomes, and (e.g. way, phenotyping disease phenotyping of a large number of clinical strains and their engineered constructs using small animal models). Q7uo -ice LS' .Z7 CON CON �_-m Personnel institutions group of The assembled management and senior staff at both institutions represent a highly experienced group of important intangible scientists who have been working together productively for the past year. This is a very important intangible which ensures that the work described in this proposal will be accomplished. SO' ASRI Personnel D. Ehrlich, Ph.D. Garth D. Ehrlich, Ph.D. Fen Z. Hu, Ph.D. Ph.D. Louisa Hiller, Ph.D. Robert Boissy, Ph.D. Azad Ahmed, M.D. M.S. Rory Eutsey, M.S. Powell, B.S. Evan Powell, B.S. Role on Project Role on Principal Investigator Principal Co-PI Bioinformatics Fellow Computational Scientist Research Fellow Research Research Fellow Research Research Assistant Research '-^ Months effort Months effort 2.4 2.4 3.6 3.6 3.6 6 6 Rockefeller personnel (3p Alexander Tomasz, Ph.D. Alexander Tomasz, Ph.D. Herminia de Lencastre Raquel Sa-Leao TBA TBA ______________________________________ _______________________________ Principal Investigator (subcontract) Investigator (subcontract) 1.2 0 Consultant 0 Consultant 12 Post doc 9.4 Graduate student - --- -------------- Grant management personnel Notes on the grant management team: The management team consists of the contracting and on the grant management team: The management team consists of the contracting PI's Drs. Ehrlich and Tomasz, as well as Dr. Hu (Co-PI), the CGS Operations Director. All subcontracting P1's Drs. Ehrlich and Tomasz, as well as Or. Hu (Co-PI), the CGS Operations Director. All three are experienced Pis and have not only operated their own laboratories for years, but have been PIs years, participants in many multi-disciplinary, multi-institutional research programs. Drs. Ehrlich and Hu have been multi-disciplinaiy, research programs. Drs. Ehrlich and Hu have been collaborators for many years and the have been working with Or. Tomasz on developing the preliminary data years Dr. year now and analysis of 4 bacterial for this application for nearly a year now (including the whole genome sequencing and analysis of 4 bacterial of and animal and experiments to strains, strains, comparatively testing the virulence of these strains and animal models and designing experiments to identify virulence genes PhD Principal Investigator 2.4 calendar months (ASRI): Dr. Ehrlich is the founder and Garth D. Ehrlich, PhD - Principal Investigator - -2.4 calendar months (ASRI): Dr. Ehrlich is the founder and executive director of the Center for Genomic Sciences (CGS), a major research department at ASRI that is at is a0' 0-a 469 O0= Sac U-aL .(0 m-� ..N E fop -... N+.. p)3 engaged in the study of a broad range of microbial and human genomic issues associated with human engaged in the study of a broad range of microbial and human genomic issues with human disease. He is also Professor of Microbiology and Immunology, and of Otolaryngology at Drexel College of disease. Re is also Professor of Microbiology and Immunology, and Otolaryngology Medicine. In addition he holds an adjunct professorship in bioengineering at CMU. He is a highly experienced Medicine. In addition in bioengineering at CMU. He is a highly experienced molecular biologist who was involved in the original application of the polymerase chain reaction to the biologist who was involved in the original application the polymerase chain reaction detection of low-copy-number infectious agents and is recognized as an authority on the molecular diagnosis recognized of infectious diseases. His text PCR-based Diagnostics in Infectious Disease has been widely used as a guide infectious diseases. His text PCR-based been used as a guide having in this field. Dr. Ehrlich together with Dr. Tomasz is the chief theoretical scientist on this project having Dr. Ehrlich together with Dr. Tomasz is the theoretical scientist on this advanced the distributed genome hypothesis (2001) to explain numerous features of chronic bacterial pathogenesis. More recently he developed the concept of applying large-scale gene association studies for pathogenesis. More applying large-scale gene association studies for the identification of disease-specific virulence genes among bacteria. The importance of these theoretical identification disease-specific virulence genes among bacteria. The importance theoretical developments has been recognized by his receiving dozens of invitations to organize and speak at national been recognized receiving to and international forums including a presentation before the NIDCD council in Sept 2004 in which some of the including council in preliminary results presented in this application were first publicly aired. In April of 2005 he organized a session presented in aired. April entitled "Innovative OM Research - Biofilms and Beyond" at the 5th Extraordinary International Symposium on Biofilms and Beyond" at the 5th Extraordinary International Symposium on Recent Advances in Otitis Media held in Amsterdam, and in May of 2006 he co-chaired a divisional symposium Recent Advances in Otitis Media held in Amsterdam, and in May of 2006 he co-chaired a divisional symposium General Meeting on "What bacterial genomes actually exist in real ecosystems, and which genes are at the ASM General Meeting on "What bacterial genomes actually exist in real ecosystems, and which genes are actually expressed in natural and pathogenic processes?" In this project, he has developed the overall expressed in natural and pathogenic processes?" In this project, he has developed the investigative strategy in collaboration with Drs. Hu, and Tomasz and is responsible for the overall experimental strategy in collaboration with Drs. Hu, and and is responsible for extensive design, interpretation of experimental results, and preparation of publications. Dr. Ehrlich has extensive experience in the design and operation of large multi-site, multi-component research proposals and is in mUlti-component and PI through scheduled calls and not infrequent trips to NYC. Dr. Ehrlich frequent contact with the subcontract P1through scheduled calls and not infrequent trips to NYC. Dr. Ehrlich animal model will be responsible for directing all of the genomics, bioinformatics, strain construction, and animal model experiments of the projects at ASRI and meets daily with Drs. Hu and Hiller, team leaders respectively for the ASRI and computational aspects of the grant. Dr. Ehrlich laboratory and computational aspects of the grant. Dr. Ehrlich will devote 20% of his time to this project and 20% and requests commensurate salary support, subject to the NIH cap. .O. 'O" 6<, = y_=o :01 070 :-: X�-3 0)O c 5,0 0)= --�p f0'1 --< ,you, x�30 fl? Dr. Fen Ze Hu, MS, PhD --Co-Investigator --2.4 calendar months (ASRI): Dr. Hu isis AssistantProfessor of Dr. Fen Ze Hu, MS, PhD Co-Investigator 2.4 calendar months (ASRI): Dr. Hu Assistant Professor of Sciences Genomics and Bioinformatics at ASRI and the Operations Director of the Center for Genomic Sciences (CGS). In addition, she has an appointment as Assistant Professor of Microbiology and Immunology at Drexel In addition, she has an appointment as Assistant Microbiology and University College of Medicine. Dr. Hu was the principal architect of the CGS high throughput genomics and principal College of Medicine. Dr. Hu CGS high genomics and Environment), and was responsible in its entirety for the bioinformatics facilities (see Resources and Environment), and was responsible in its entirety for the bioinformatics facilities (see Resources operationalization of the Center. She has intimate and detailed knowledge of all of the complex knowledge operationalization of the Center. She has intimate all instrumentation and robotic platforms that will be required to efficiently carry out the proposed researches. Of instrumentation and robotic platforms that will be required to efficiently carry out the proposed researches. Of particular importance to the incumbent application, Dr. Hu worked in collaboration with the 454 LifeSciences Dr. collaboration team on the development of the sequencing technology for the two years prior to its public release-CGS was development of the sequencing technology for the two years prior to its public release-CGS was 20TM, part Dr. one of the first five sites world-wide to take delivery of the Genome Sequencer 20TM, due in no small part to Dr. five world-wide to Hu's long term involvement with the 454 development staff. Dr. Hu is an efficiency expert who has developed term involvement with the 454 development staff. developed countless time and money saving protocols in both laboratory automation and bioinformatics. As part of her time and money saving protocols in both laboratory automation and bioinformatics. part her still in use handling, manipulation, and graduate work she developed a suite of programs that are still in use today for the handling, manipulation, and transformation of large genomic data sets used for gene association and mapping studies. Dr. Hu has worked data sets used for gene association and mapping studies. Dr. worked with Dr. Ehrlich for over a decade. She has been responsible for the hiring and training of much of the decade. She has been responsible assembled ASRI staff including Drs. Hiller, Boissy, and Ahmed, as well as Messrs. Eutsey, and Powell. Dr. Hu assembled ASRI staff including Drs. Hiller, Boissy, and Ahmed, as well as Messrs. Eutsey, and Powell. Dr. Hu will have direct oversight of all of the DNA sequencing work and Drs. Ahmed and Hiller will report to her on the and Hiller report her on technical aspects of the sequencing and comparative genomic aspects of the work. Dr. Hu will devote 20% the sequencing and comparative genomic aspects of the work. 20% effort to this project and requests commensurate support; this reflects a 5% reduction in effort from the application. previous application. -0O f/! 17< f?, -mov_0� gyp) �'N (�Q O-. ao-6 4'. 341 -(o vw- "NO 0.. Alexander Tomasz PhD - Rockefeller University - Subcontract P1 -1.2 calendar months: Dr. Ott is a Subcontract PI - 1.2 calendar months: Dr. PhD - Rockefeller is a world renowned statistical and population geneticist and is widely regarded as the modern day father of linkage analysis and gene association studies. He has been Head of the Laboratory of Statistical Genetics at the association studies. He has been Head of the Rockefeller University for years, and also holds senior faculty positions at Columbia University, the Beijing University for years, and also faculty positions at Columbia Genomics Institute of the Chinese Academy of Sciences, and Shanghai Jiao Tong University. He has undisputed references published several seminal monographs and treatises on these topics which serve as the undisputed references for this field. In addition Dr. Ott has published prolifically in the primary scientific literature. Dr. Ott will be Dr. addition Dr. those responsible for the design and oversight of the genic association studies to statistically identify those genes 70C ;:L .gyp. N.. LS" M.. fl: Q'� -'. f/1. ocy U., Q-0 0.- .0. E ..L 0.C c�cwU�u y0.., y-. C-... CD- c`� Q-- a)2 yo,/) LOS moo N>> L.g Q!" m.0 N-C C'> E-o 'O^ r_045 '_O Co>0 �-a +_- '_�6 from the pneumococcal supragenome that are associated with virulence in otitis media and other disease phenotypes. Dr. Ott requests salary support commensurate with his effort subject to the NIH cap. cap. Dr. Ott requests salary commensurate with his effort subject Laboratory Management Personnel on the Laboratory Management Team: Drs. Hu and Hiller comprise highly effective laboratory Notes on the Laboratory Management Team: Drs. Hu and Hi//er comprise aahigh/y effective laboratory of preliminary management team who have worked successfully together in the development of the preliminary data for this proposal. Collectively, they possess the requisite ta/ents and ski//s to ensure that any project moves forward any project moves forward proposaL Collectively, they possess the requisite talents and skills expeditiously. As team they have: 1) extraordinary laboratory skills; 2) excellent needs evaluation skills; 2) expeditiously As aa teamthey have: 1) extraordinary /aboratory ski//s; 2) excellent needs evaluation ski/Is; 2) systems design and trouble shooting skills; 3) superb analysis skills; and 4) personnel and time management ski/Is; 3) superb analysis ski//s; and 4) personne/ and time management skills. Dr. Hu, also a member of the grants management and the data analysis and computational teams helps ski//s. Dr. Hu, also a member of the grants management the data analysis computationa/ teams he/ps to co-ordinate the overall aims of the grant and ensure communication throughout the various programmatic overal/ aims the grant communication atom f]7 ;7, '"' components. Dr. N. Luisa Hiller, PhD -- Head of Bioinformatics (ASRI) --3.6 calendar months: Dr. Hiller is aarecent key Dr. N. Luisa Hiller, PhD Head of Bioinformatics (ASRI) 3.6 calendar months: Dr. Hiller is recent key recruit to CGS (2006). She received her PhD and post-doctoral training from Northwestern University where to CGS (2006). training from Northwestern University where for Plasmodium and she discovered, using computational tools that she developed, a major new secretome for Plasmodium and resulting in a author publication Science. Then, within months of joining CGS, working other parasites - resulting in a first author publication in Science. Then, within months of joining CGS, working in J. together with Dr. Hu, she published a comparative genomics paper on 17 pneumococcal strains in .1 Bacteriol which is the largest comparative genomics paper ever published within a species. She is both an excellent lab comparative genomics paper ever published within a species. lab of scientist and a supremely gifted bioinformatician and will utilize both skill sets in the performance of this project. Dr. Hiller together with Dr. Boissy has responsibility for genome assembly, ORF-calling, automated project. Dr. Hiller together with Dr. Boissy has responsibility for genome assembly, ORF-calling, automated annotation, global comparative genomics among strains, and maintenance of the core and supragenome primary interface Dr. Dr. Hiller will provide databases. Dr. Hiller will provide the primary interface with Dr. Ehrlich in choosing target genes for strain strain engineering. Dr. Hiller with devote 30% effort to this project and requests commensurate support. support. engineering. Dr. Hiller with devote 30% effort to this project OCD (n2 gyp.. o_- �-o N-4 :,m 500 an) Computational Personnel Personnel '++ Notes on the Data Analysis and Computational (DAC) Team: Dr. Hi/ler wil/ serve as the DAC team /eader on the Data Analysis and Computational (DAC) Team: Dr. Hiller will seNe as the DAC team leader and analysis among the sites (ASRI, Rockefeller). will and will co-ordinate data flow and analysis among the sites (ASPI, Rocke fe//er). She wi/I be assisted in these endeavors by Dr. Boissy. Dr. Hu wi/I also serve on DAC team and will provide a natural interface with the a natural interface with Dr. Boissy Dr. Hu will also seNe on DAC team and will of Management team. The DAC team is composed of extremely talented individuals with proven track records in team. The team their various areas of expertise making this a particular strength of this proposal. The importance of various areas of expertise making this a particular strength of this proposaL The importance of bioinformatics for a project such as this can not be over-emphasized and CGS is fortunate to have such an not be fora project such as this fortunate such an experienced team on-hand to interact with the international caliber staff at the subcontracting institution. Robert Boissy, PhD - Senior Research Associate (ASRI) --3.6 calendar months: Dr. Boissy was recruited PhD (ASRI) 3.6 calendar months: Dr. Boissy was recruited Research to the CGS jointly by Drs. Ehrlich and Hu from the private sector four years ago. Dr. Boissy develops Drs. Ehrlich and Hu from the private sector four years ago. computational infrastructure and has been responsible for a major updating of the entire CGS bioinformatics computational infrastructure and platform and is responsible for the extensive time grant CGS has from the Pittsburgh Supercomputing Center and responsible for the from the which we use for our matrix comparisons. Since joining CGS he has built and brought on line 3, 64 bit servers, CGS matrix comparisons. Since servers, parsing smoothly platform developed dozens of operational efficiencies for the parsing and movement of data smoothly from platform to platform and the automated updating of numerous databases and applications. He is the developer of the platform and the automated updating of numerous databases and applications. developer the novel patented relational database structure for the parsing of complex sequence features which we are using novel patented relational database as one of our comparative genomic tools. Dr. Boissy heads the CGS collaboration with the PGAAP group at comparative genomic tools. Dr. Boissy heads group at ORF-calling and the NCBI as home of the automated annotation pipelines that we use for whole genome ORF-calling and as home of the automated annotation pipelines pipelines that are used by Dr. Hiller for her global comparative genomic analyses. automated annotation - pipelines that are used by Dr. Hiller for her global comparative genomic analyses. of contig data prior One of Dr. Boissy's other roles is the creation of pseudochromosomes from the 454 contig data prior to submission for annotation. Salary support is requested commensurate with his percent effort. submission annotation. Salary support is requested commensurate via y�,Qn �03 QC) ton (:3 ti, �;41 �'.� �-., ,9-.1 3+. .per. ,O_ p0) (n- m"',- �-v .p.. 3'g Meg Dalgren, B.S., M.S. -Information Systems Architect - 0 calendar months (ASRI): Ms. Dalgren is an months (ASRI): Ms. Dalgren is Meg Dalgren, B.S., M.S. - Information Systems Architect m-0 resource, recruited from biostatistician institutional resource, recruited from UC Berkley where she worked as programmer and biostatistician who will provide - on an as needed basis - complex programming support, trouble shooting, and support for the on an as needed complex programming support, trouble shooting, and support for informatics aspects of genome finishing. No support is requested. aspects of genome finishing. No support is requested. �-m (pg p'1 pi, m�' `-G 3'= ..� iris 0>E OIL .."O. =rn a�� ass= s-0 foil yob E =�. as===�n-C --> =�= ."'O"' '";.m�� m__ `O' +'_. .'O- �.o mom �'- moo 's� .-L- $-6 Laboratory Personnel Azad Ahmed, MD - Research Fellow - 3.6calendar months (ASRI): Dr. Ahmed was recruited to the CGS Research -3.6 calendar months (ASRI): Dr. Ahmed was recruited to the CGS by Dr. Hu (to whom he reports) seven years ago and since that time he become a superb molecular biologist. Dr. (to whom he reports) seven years and since that time he biologist. He has recently distinguished himself as the most proficient DNA sequencer around as was single-handedly He has recently distinguished himself as the proficient DNA sequencer around responsible for the 5 day turn-around of the WGS of strains 459-2 and 459-5 that were received at CGS less responsible for the 5 day turn-around of the WGS strains 459-2 and 459-5 that were received CGS less than two w...